Genome Editing and Biological Effects Testing Component

Genome Editing and Biological Effects Testing
PROJECT SUMMARY / ABSTRACT
The overarching goal of the Genome Editing and Biological Effects Testing Component of the Center for
Somatic Cell Genome Editing in Nonhuman Primates is to test delivery reagents and editing tools developed
by investigators in wild-type, reporter, and disease models. Studies performed will address the efficiency,
specificity, and safety of genome editing technologies, including the duration of editing activity, and the
potential for inflammation and immunogenicity. Nonhuman primates will be provided through the Resource
Component, and the Coordination Component will ensure studies are well managed and prioritized, with
efficient data collection, analysis, and sharing. The Genome Editing and Biological Effects Testing Component
will work directly with investigators and utilize demonstrated capabilities to test a range of viral and nonviral
vectors and contribute to the acceleration of the translation of somatic cell genome editing technologies into
treatments for human diseases. The Genome Editing and Biological Effects Testing Component will address
the following Specific Aims: (1) Evaluate somatic cell genome editing across age groups in nonhuman
primates, and (2) Assess biological effects, safety, and the potential for inflammation and immune responses in
nonhuman primate models. The Genome Editing and Biological Effects Testing Component team has the
expertise and flexibility to work with investigators to quantify any desired type of genome editing event (e.g.,
on-target, off-target, large rearrangements, duration of editing, cell specificity), and in any organ system, cell
population, or age group. Paired with a robust Resource Component, and through the infrastructure of the UC
Davis Genome Center, California National Primate Research Center, and Clinical and Translational Science
Center, the Genome Editing and Biological Effects Testing Component will deliver the data needed to
comprehensively assess the promise of new somatic cell genome editing technologies developed by
investigators.